Anti-norovirus protease inhibitors for immunocompromised patients

PROJECT SUMMARY/ABSTRACT
Human Noroviruses (hNoV), which belong to the Caliciviridae family, are the leading cause of viral gastroenteritis
and food-borne disease worldwide. Each year in the United States alone, hNoV is responsible for greater than
21 million cases of acute gastroenteritis, leading to an estimated 71,000 hospitalizations per year. While most
cases resolve within a week, immunocompromised patients, children, and the elderly have an elevated risk of
long-term and even fatal infections. Currently, there are no antiviral drugs or vaccines approved for the prevention
or treatment of chronic hNoV infections. The main goal of this project is to harness the medical benefits that are
offered by the inhibition of viral enzymes, including the hNoV protease. The overall objective of this proposal is
to design and develop a protease inhibitor for the treatment of hNoV infections. The hNoV NS6 protease has
become an attractive drug target due to its essential role in the viral replication cycle. The central hypothesis is
that small-molecule inhibitors targeting the viral protease will limit or eliminate hNoV infections. The rationale for
the proposed research is based on our preliminary data, specifically compound 1 and its analogs. These
compounds are unique, non-toxic, small peptidomimetic molecules that inhibit NoV replication selectively in
culture at 20 nM EC50 by interacting with the hNoV protease. Pharmacological manipulation of the hNoV protease
is expected to result in new and innovative approaches to the prevention and treatment of NoV infections. Guided
by strong preliminary data, this hypothesis will be tested by pursuing three specific aims: Aim 1) To optimize and
discover and develop broad-spectrum oral NoV PIs by multiparameter optimization and molecular modeling
approaches of lead compounds from our proprietary library. Aim 2) To perform mechanism of action (MOA) and
resistance studies of the lead NoV PIs. Aim 3) To evaluate the lead NoV PIs in an immunocompromised mouse
model. Under the first aim, about 25 compounds will be designed, synthesized, and tested per year. Under the
second aim, enzyme kinetic, crystallographic, host protease inhibition, inhibition of NoV protease production,
and drug resistance studies will be performed with the lead compounds. Under the third aim, anti-NoV efficacy
studies will be performed in an immunodeficient mouse model. This approach is innovative because we
developed a research plan taking full advantage of five recent advances: (1) producing hNoV PR recombinant
proteins in milligram amounts; (2) solving the crystal structure of the NoV GII.4 PR - the main drug target; (3) a
cell-based hNoV replicon assay; (4) 3D human intestinal enteroid model, and (5) an immunocompromised mouse
disease model to study human NoV infection. The proposed research is significant because in-depth pre-clinical
studies and characterization of these new peptidomimetics could lead to the approval of the first safe and
effective drugs for the treatment of chronic hNoV infections which cause significant morbidity and mortality in
immunocompromised patients.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because human Noroviruses (hNoV) are the leading cause of viral gastroenteritis and food-borne disease worldwide. NIAID/NIH has designated Caliciviruses (including hNoV) as an “Emerging Infectious Disease Category B Priority Pathogen.” Currently, there are no antiviral drugs or vaccines approved for the treatment of hNoV infections, and therefore, the goal of this proposal is to design and develop a series of specific and safe small-molecule inhibitors targeting a critical viral protein required for virus replication and thus limit or eliminate hNoV infections in immunocompromised patients.